REGULATORY AFFAIRS CONSULTANT SUPPORT SERVICES

Regulatory affairs support for the development of therapies for pain; pain therapy development program

Public health relevance
Regulatory affairs support for the development of therapies for pain; pain therapy development program